CHEMICAL, STRUCTURAL, AND MORPHOLOGICAL STUDIES ON CALCIUM PHOSPHATES

The purpose of this project is to study the physical, chemical, and ultrastructural properties of calcium phosphate salts, and to clarify the kinetic and thermodynamic processes and the interactions with substances of biological interest that uniquely enable calcium phosphate salts to carry out their specialized role in vivo. The properties of calcium phosphate salts are being studied with a variety of ultrastructural and physical-chemical techniques such as electron microscopy, x-ray diffraction, surface area analyses, chromatographic and standard analytical chemistry procedures. A principal endeavor currently being pursued involves artificial lipid vesicles (liposomes) as in vitro models to investigate physico- chemical aspects of matrix vesicle (MV)-mediated calcification in vivo. The latest phase of this endeavor is a study that is examining the effect that organic phosphonates have on mineral development in the liposomal model system. The aim of this study is to better delineate the physicochemical basis for the observed suppressive effects bisphosphonates have on biological calcification. Another current effort under this project is to study the physicochemical effects biologically important ions such as fluoride, carbonate, and magnesium have on the texture, i.e., size/shape of apatite crystals grown in vitro under constant physiological-like solution conditions. The aim of this study is to distinguish the direct effect fluoride has on the texture of biological apatites from that brought about by the metabolic and matrix changes this ion induces in vivo.